Dissecting Innate Immune Responses to Salmonella Enteritidis

Project Summary and Abstract
Salmonella enterica is the leading cause of food-borne hospitalizations in the United States. The Salmonella
enterica species includes over 2500 circulating sub-species, or serovars, which cause disease ranging from self-
limiting gastroenteritis to severe systemic disease and death. Studies of Salmonella pathogenicity and host
immune responses to Salmonella rely on a limited number of commonly used reference S. enterica serovar
Typhimurium (STm) or Typhi strains. While these studies have defined fundamental mechanisms of host-
Salmonella interactions, they do not reflect the broad genotypic or phenotypic diversity among Salmonella
enterica species, suggesting a crucial gap in our understanding of host responses to Salmonella. How the innate
immune system recognizes and responds to other Salmonella serovars is of particular interest, as a significant
fraction of disease is caused by serovars other than Typhi or Typhimurium. The innate immune system plays a
crucial role in host defense against infection, and therefore represents a particularly attractive target for study.
Salmonella invades and replicates within macrophages and utilizes a conserved type III secretion system
encoded by a genomic region termed the Salmonella Pathogenicity Island 2 (SPI-2), to inject virulence factors,
known as ‘effectors’, into the host cytosol. These effectors manipulate the host environment and permit
Salmonella maintenance of an intracellular niche. SPI-2 effectors display intra- and inter-serovar genetic
diversity, which contributes to important differences in host responses to infection. While effectors are important
for bacterial virulence, they also enable the host to detect intracellular bacteria. One mechanism of innate
immune recognition involves cytosolic innate immune sensors that detect bacterial ligands or the activity of
effectors within the cytosol which activate the inflammatory caspases -1 and/or -11 (Casp1/11). Casp1/11 cleave
and activate IL-1 family cytokines and the pore-forming protein Gasdermin-D (GSDMD), leading to an
inflammatory cell death termed pyroptosis. Casp1/11 are necessary for pyroptosis in response to commonly
studied strains of S. Typhimurium. Intriguingly, in contrast to prior studies, my preliminary studies show for the
first time that multiple S. enterica clinical isolates of different serovars, including S. Enteritidis, trigger Casp1/11-
independent GSDMD cleavage, IL-1 release, and cell death. Moreover, my preliminary studies further
demonstrate that S. Enteritidis, and other clinical isolates, induce this Casp1/11-independent cell death in a SPI-
2-dependent manner. These data and as well as additional preliminary findings discussed in this proposal,
provoke the hypothesis that Salmonella Enteritidis possesses a unique SPI-2 effector which triggers
Casp8-mediated pyroptosis. In this proposal, I aim to define the host pathways mediating Casp1/11-
independent cell death in response to clinical Salmonella isolates (Aim 1), and the bacterial factor(s) responsible
for triggering this cell death (Aim 2). The proposed project will expand our understanding of Salmonella
pathogenesis and host-responses to currently circulating strains.

Public health relevance
Project Narrative Our understanding of immune responses to Salmonella relies on a limited number of well-characterized S. enterica serovar strains, primarily Typhi and Typhimurium, even though over 2500 circulating serovars of Salmonella exist, with S. Enteritidis being among the most frequent cause of Salmonella disease and food contamination. My preliminary data reveals that S. Enteritidis induces a previously undefined pathway of inflammatory cell death distinct from our current understanding of Salmonella-induced pyroptosis. This proposal aims to identify host mechanisms resulting in S. Enteritidis-induced cell-death (Aim1), and the unique bacterial effectors responsible for induction of cell death (Aim2).